Nitro-nitrate fatty acid derivatives as novel cGMP-dependent and cGMP-independent signaling mediators

PROJECT SUMMARY
Organic nitrate esters are long-appreciated treatments for cardiovascular disease (CVD), leading causes of
death worldwide. Of note, organic nitrates have never been detected biologically, and their vasodilatory effects
are attenuated by the development of nitrate tolerance and endothelial dysfunction, highlighting an urgent need
for alternative therapies. In this context, dietary interventions reduce CVD incidence and mortality. While benefits
of the dietary interventions are clinically well documented, new data continues to emerge as to the contributions
of individual dietary constituents in mediating beneficial downstream responses. Consumption of fruits,
vegetables, meat, and dairy products provides a rich source of conjugated linoleic acid (CLA) and the inorganic
anions nitrite (NO2−), and nitrate (NO3−). Strong evidence reveals that NO2− and NO3− are readily transformed
by metabolic and inflammatory conditions promoting nitration of CLA and yielding electrophilc nitroalkene
derivatives (NO2-FA), which induce reversible alkylation of nucleophilic cysteine (Cys) residues with consequent
post-translational modification (PTM) of many functionally-significant regulatory proteins. Preclinical and clinical
data affirm that NO2-FA induce pleiotropic adaptive and anti-inflammatory gene expression responses. We
recently reported that the acidic gastric environment and the conjugated double bound of CLA results in a novel
NO2−-mediated unsaturated fatty acid nitration mechanism that is critical for generating organic nitrate-containing
fatty acid derivatives, termed nitro-nitrate fatty acids (NO2-ONO2-FA). Preliminary data indicates that NO2-ONO2-
FA: a) are not only endogenously-generated in vivo by digestive reactions of CLA + NO2− but also upon ex vivo
myocardial I/R injury, b) survive intestinal absorption, are incorporated into chylomicron triglycerides and reach
the systemic circulation, c) are non-electrophilic that then decay to an electrophilic NO2-FA product after
releasing secondary nitrogen oxides and d) can induce concerted salutary PTM effects and guanylate cyclase
activation. From this insight, it is now hypothesized that NO2-ONO2-FA derivatives promote vasodilation and
inhibit cardiovascular inflammatory responses via both cGMP-dependent and cGMP-independent
signaling actions. The rationale for pursuing this project is to define the biochemical formation and unique PK
and signaling actions of NO2-ONO2-FA, that current data support is a small molecule mediator that displays the
pharmacology of both organic nitrates and Cys-reactive electrophiles. We also better define the scope of
endogenous products stemming from the metabolic reactions of both a healthy diet and inflammation. The goals
of the proposal are: 1) to define the metabolic and inflammatory generation and PK of NO2-ONO2-FA and 2) to
quantify the in vitro and in vivo cardiovascular responses to NO2-ONO2-FA in the context of both vasodilatory
and vasoprotective cGMP-dependent and cGMP-independent signaling. Successful completion of the proposed
research plan can lay the foundation for a safe pharmacological strategy targeting inflammatory-related CVD.

Public health relevance
PROJECT NARRATIVE A novel class of dietary-derived nitro-fatty acid hybrids having dual nitrate ester (R-ONO2) and nitroalkene (R- NO2) substituents (NO2-ONO2-FA) is proposed to promote vasodilation and inhibit cardiovascular inflammatory responses via both cGMP-dependent and cGMP-independent signaling actions, establishing a safe pharmacological strategy targeting inflammatory-related CVD.